Bridging the Gap: Evaluating why and how to implement lifestyle programs for cancer patients into routine clinical oncology care

Abstract
Mounting evidence suggests that obesity at breast cancer diagnosis is associated with poorer survival.
Far fewer studies have described weight patterns in the post-diagnosis period or explored how post-diagnosis
weight patterns impact cancer outcomes. Those that have, had important limitations making it challenging to
draw strong conclusions and direct resources to the most appropriate populations. However, the adverse role
of obesity in breast cancer risk has driven the development of diet and exercise recommendations and lifestyle
behavioral programs for cancer prevention and control. Studies have shown adherence to these
recommendations can improve overall quality of life, body composition, and surrogate markers of mortality in
women with breast cancer. Unfortunately, few breast cancer survivors currently meet the nutrition and physical
activity guidelines or report discussing diet and exercise with their oncologist. This highlights an important
evidence-practice gap which partially exists because research to date has focused on the efficacy of lifestyle
interventions with less attention on how these interventions might be translated into clinical practice.
Guided by the RE-AIM (Reach, Effectiveness, Adoption, Implementation and Maintenance) framework,
the goal of this application is to clarify the potential benefits of bringing behavioral lifestyle programming into
routine oncology care and demonstrate how to do so in a scalable, sustainable, and cost-effective way using
breast cancer as a model. First, we will describe weight patterns after breast cancer diagnosis by leveraging
electronic health record data from a large, diverse healthcare network. We will apply novel longitudinal
methods to define the population who could benefit from lifestyle counseling and to inform the most appropriate
time to intervene. Second, we will conduct a mixed methods study to explore the experiences of women with
breast cancer participating in a nutrition and exercise intervention during chemotherapy. From the patients'
perspective, we aim to uncover motivations, preferences, and perceived barriers to and facilitators of adhering
and sustaining a nutrition and exercise intervention during active cancer treatment. Lastly, we will estimate the
cost-effectiveness of the same comprehensive nutrition and exercise intervention for breast cancer patients
undergoing chemotherapy to provide critical data that can help inform the scaling-up of behavioral
interventions in the oncology setting.
An interdisciplinary team of renowned investigators was assembled from the Yale School of Public
Health and the Yale School of Medicine to provide direct research support and professional development
mentorship to the applicant. The proposed research and the collaborative training environment at Yale will
enable the applicant to hone her existing skillsets and gain specialized expertise that will position her well for a
competitive post-doctoral position and a long-term career as an independent investigator working to implement
lifestyle behavioral counseling into the standard of oncology care.

Public health relevance
Narrative While research supports the benefits of adhering to healthy lifestyle behaviors during breast cancer treatment, the uptake of these behaviors remains relatively low, highlighting an important evidence-practice gap. The proposed application applies implementation science methodologies to describe the breast cancer populations who would benefit most from weight management counseling, uncover barriers to and facilitators of behavior change during treatment for breast cancer survivors, and estimate the cost-effectiveness of an existing lifestyle behavioral program. Taken together, these results will generate additional evidence that can be shared with key stakeholders to support the integration of nutrition and physical activity counseling into routine clinical oncology care.